Metabolic control of exit from naïve pluripotency

PROJECT SUMMARY
Cellular metabolic pathways exhibit remarkable plasticity across different cell types in both development and
disease. In addition to accompanying changes in cell state, metabolic rewiring has been shown to drive cell fate
decisions programs by altering the chromatin landscape. The deposition of chemical modifications that decorate
chromatin requires the intermediates of metabolic pathways, and several enzymes that remove these marks use
metabolites as part of their enzymatic reaction. Therefore, fluctuations in metabolite levels have the capacity to
shape chromatin to effect cell fate-specific gene expression, but the metabolic changes that drive chromatin
reorganization and the enzymes that mediate metabolic control of cell fate during early development remain
largely unknown. We have previously identified specific metabolites that control self-renewal of mouse embryonic
stem cells (ESCs). Whether metabolism is altered as ESCs exit the self-renewing pluripotent state, and whether
these metabolic changes are required for multi-lineage differentiation remains an open question.
The goal of this research proposal is to characterize the metabolic rewiring that occurs during exit from
naïve pluripotency and to determine the mechanisms by which this rewiring controls mouse ESC
differentiation. Our preliminary data indicate that exit from naïve pluripotency is accompanied by an increase
in the mitochondrial export of citrate. In Aim 1, we will use genetic and pharmacologic approaches to target the
mitochondrial citrate transporter SLC25A1 or the downstream citrate-catabolizing enzyme ATP-citrate lyase to
test the hypothesis that mitochondrially-derived citrate is required for early differentiation. We will investigate
whether this metabolic change regulates cell fate through the deposition of citrate-derived histone acetylation
marks. Preliminary data also shows changes in cellular redox state marked by an increase in the cytosolic
NAD+/NADH ratio during early differentiation. In Aim 2, we will determine if this metabolic change is required for
exit from naïve pluripotency by modulating the NAD+/NADH ratio using pharmacological or genetic tools. Further
experiments will identify the mechanism by which cellular redox state signals to the chromatin landscape to
dictate cell fate. These studies will reveal the mechanisms of metabolic control during exit from naïve pluripotency
and will provide critical insight into how metabolic regulation contributes to changes in cell identity during
embryonic development. The work and training plan outlined in this proposal will be completed in the laboratory
of Dr. Lydia Finley with the co-advisement of Dr. Kristian Helin at Memorial Sloan Kettering Cancer Center and
will ideally prepare the applicant for further clinical training and a career as an independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Metabolic activity is dynamically regulated across cell states in development and disease and can contribute to the establishment of cell fate through metabolite-dependent effects on chromatin organization. The goal of this research proposal is to identify the mechanisms by which metabolic pathways drive chromatin changes to support the exit from naïve pluripotency in mouse embryonic stem cells. These studies will enhance our understanding of how metabolic control of gene expression enables successful execution of developmental programs.